CT Volume Measurement of Lung Cancer treated with Erlotinib: Genomic Correlation

Project Summary Lung cancer is a leading cause of cancer death in the United States and worldwide. One of the recent breakthroughs in lung cancer treatment was the discovery of the somatic activating mutations of the epidermal growth factor receptor (EGFR) tyrosine kinase domain in non-small cell lung cancer (NSCLC), which is associated with a dramatic clinical response to EGFR inhibitors such as gefitinib and erlotinib. Erlotinib is particularly effective in patients with EGFR mutations. However, most patients with initial responses to erlotinib treatment eventually relapse due to acquired resistance to erlotinib. The purpose of this proposal is to analyze chronological changes in tumor size and volume in advanced NSCLC patients treated with erlotinib in clinical trials at Dana-Farber Cancer Institute, and determine if the tumor volume detects relapse caused by acquired resistance earlier than the tumor size does. If this is proven, tumor volume can be used as the primary marker for monitoring response to therapy instead of the conventional marker, tumor size. Early detection of acquired resistance to erlotinib by tumor volume analysis will allow oncologists to change therapeutic regimen for prolongation of progression-free survival. We also aim to determine if the initial proportional decreases in tumor size and volume correlate with progression-free survival and overall survival of the patients. If this is the case, tumor volume measured by CT can be used as a biomarker for prognosis. We will also determine if the tumor size and volume changes correlate with genomic changes in circulating tumor cells and free plasma DNA in advanced NSCLC patients. Genomic analysis of circulating tumor cells and free plasma DNA in NSCLC is an emerging non-invasive technique which allows for frequent assessment of genomic changes during therapy. The study will be performed using data collected in phase II prospective clinical trials of erlotinib in advanced NSCLC patients at the Dana-Farber Cancer Institute. Data includes chest CT examinations performed every eight weeks and EGFR mutation analysis. Tumor size and volume will be measured using a commercially available, Food and Drug Administration (FDA) approved volume analysis software. Changes of tumor size and volume will be calculated, and will be correlated with clinical outcome and genomic analysis results. The long term goal of the project is to determine the imaging parameters that most efficiently predict acquired resistance to erlotinib by integrating the genomic information into the tumor volume analysis, in order to optimize the therapeutic benefit of erlotinib and contribute to the prolongation of survival in lung cancer patients.

Public health relevance
Project Narrative Lung cancer is a leading cause of cancer death in the United States and worldwide needing more effective treatment options. The epidermal growth factor receptor tyrosine kinase inhibitor, erlotinib, has emerged as an attractive therapy for non-small cell lung cancer with a dramatic clinical response; however, most patients with initial responses eventually relapse due to acquired resistance. We aim to perform detailed chronological analysis of tumor size and volume in correlation with genomic information obtained from biopsy specimens, circulating tumor cells, and plasma DNA in lung cancer patients treated with erlotinib for early detection of resistance to erlotinib and prolongation of survival. __SpecificAimsTextDelimiter__ Specific Aims Lung cancer is a leading cause of cancer death in the United States and worldwide, accounting for over 160,000 deaths per year in the United States. Eighty-five percent of subjects have non-small cell lung cancer (NSCLC), in which the 5-year survival rate is only 15%. More effective treatment options are clearly needed. Erlotinib, an inhibitor of the tyrosine kinase domain of the epidermal growth factor receptor (EGFR), has emerged as an attractive therapy for NSCLC and is associated with a dramatic clinical response in patients with sensitizing mutations of the EGFR. However, all patients with initial responses eventually relapse due to acquired resistance to erlotinib caused by a secondary T790M mutations or amplification of the MET oncogene. Medical oncologists typically rely on changes in one-dimensional tumor size measured by computed tomography (CT) scans as the major determinant in defining tumor progression and in deciding when to change therapeutic regimen. With the emerging definitions of the pathogenesis of erlotinib resistance and new therapies targeting these mechanisms, development of radiographic methods to detect emerging resistance to erlotinib has the potential to provide a significant clinical impact by improving the efficacy of lung cancer treatment. Recent technical advances in tumor genomic analyses and their clinical applications have enabled characterization of lung cancer either from CT-guided biopsy specimens or from circulating tumor cells (CTCs) and plasma DNA. These minimally-invasive monitoring mechanisms are now providing a potential means for following evolving genomic changes over time. The correlation of genomic analyses with quantitative imaging metrics including CT tumor volume will help to establish a method of imaging-based lung cancer assessment which reflects the underlying biological and genomic properties of tumor in individual patients. Currently, three clinical trials are ongoing at the Dana-Faber Cancer Institute: (1) Phase II, open-label trial of erlotinib in women with previously untreated advanced lung adenocarcinoma; (2) Phase II, open-label nonrandomized study of first-line erlotinib therapy and the subsequent development of secondary resistance mechanisms in NSCLC patients and known sensitizing EGFR mutations; and (3) a prospective, observational study collecting and analyzing CTCs from advanced NSCLC patients with EGFR mutations starting erlotinib. The purpose of this proposal is to analyze chronological changes in tumor size and volume in NSCLC patients during erlotinib therapy in these cohorts, and correlate tumor size and volume changes with survival and the genomic information of the tumor obtained from CTCs and plasma DNA. The study aims for developing imaging-based method of lung cancer assessment which reflects molecular and genomic behavior of the tumor. Specific Aim 1: Determine if the tumor volume detects relapse caused by acquired resistance earlier than the tumor size does in advanced NSCLC patients treated with erlotinib. We hypothesize that the tumor volume detects relapse due to acquired resistance earlier than the tumor size does. We will first perform chronological measurements of tumor size and volume in advanced NSCLC patients treated with erlotinib in Trials 1 and 2 using CT data obtained during phase II clinical trials of erlotinib with commercially available, Food and Drug Administration (FDA) approved volume analysis software. We will then calculate the percent changes of the tumor size and volume in reference to the smallest tumor size and volume since the baseline, and assess relapse using size criteria defined by Response Evaluation Criteria in Solid Tumors (RECIST) and volumetric criteria defined based on our preliminary data to prove our hypothesis. Specific Aim 2: Ascertain if the initial proportional decrease in tumor size and volume, as well as the actual residual tumor size and volume after initial response, is related to the duration of progression- free survival and overall survival in advanced NSCLC patients treated with erlotinib. We hypothesize advanced NSCLC patients treated with erlotinib with a greater initial proportional decrease in tumor size and volume are more likely to have longer time to progression and longer survival than those with a proportionally smaller decrease. We also hypothesize that the patients with smaller actual residual tumor size and volume will have longer time to progression and survival than those with larger residual tumor size and volume. If this is the case, the assessment of tumor size and volume can serve as an early predictor of progression-free and overall survival and help optimizing the treatment options for prolongation of the survival. Specific Aim 3: Determine when the mutations responsible for acquired resistance are detected in circulating tumor cells (CTCs) and plasma DNA in relation to the chronological changes of tumor size and volume in advanced NSCLC patients treated with erlotinib. In patients enrolled in Trial 2 and 3, we aim to evaluate when the mutations responsible for acquired resistance, MET amplification and T790M mutation, are detected in CTC and plasma DNA in relation to the chronological changes of tumor size and volume. Determining if the resistance mutations are detected before, at the same time, or after the relapse based on tumor size and volume will help to establish a strategy for response assessment of lung cancer treated with erlotinib which integrates both imaging-based and genomic information.